Beta-adrenergic mediated suppression of T cell chemotaxis by cancers

ABSTRACT Tumor growth induces local and systemic immunosuppressive effects that diminish immune cell infiltrationoftumors,therebylimitingtheefficacyofTcell-basedimmunotherapies.Wepreviously demonstrated that restoration of interferon signaling and downstream expression of CXCR3 cognate chemokines is sufficient to restore T cell infiltration of tumors. However, the mechanisms that modulate chemokine production and T cell infiltration in tumors remain poorly defined. Recent studies have reported that mice maintained at standard vivarium temperatures (ST conditions, ~24°C) experience chronic cold stress and induction of β-adrenergic signaling, including induction of high levels of circulating norepinephrine (NE), relative to mice maintained in thermoneutral (TN) conditions (28-30°C). Significantly, tumors grow more rapidly in ST- conditioned mice, concurrent with reduced CD8 infiltration and chemokine production. Thus, tumors in ST mice immunologically resemble patient-derived samples (NE replete and lacking chemokine and T cell infiltrates), suggesting that stress-induced signaling pathways may play a major role in limiting immune responses to tumors. We propose that β-adrenergic signaling suppresses interferon and interferon-inducible chemokine production (including CXCR3-cognate chemokines CXCL9 and CXCL10) in the tumor microenvironment, thereby limiting CXCR3+CD8 T cell infiltration and immune-mediated tumor rejection. By extension, blocking β-adrenergic signaling may induce or restore interferon-inducible chemokine production and CXCR3+ T cell infiltration in tumors. In this exploratory/developmental study, we will 1) investigate the role of β- adrenergic signaling in regulation of chemokine production and T cell trafficking to the melanoma microenvironment; and 2) assess the impact of β-adrenergic signaling on T cell-based therapies for cancer. These studies will inform future R01-scale investigations of the specific molecular and cellular mechanisms of action in stress-mediated changes in the tumor microenvironment, and provide a conceptual basis to translate these preclinical studies into clinical Phase 0/1 trials that combine β-blockers and cancer immunotherapy for the purpose of enhancing T cell infiltration and anti-tumor efficacy.

Public health relevance
NARRATIVE Pursuing the scientific premise that -adrenergic signal compromises anti-tumor immunity through suppression of adaptive immune access of the tumor microenvironment, we propose to evaluate the hypotheses that 1) - adrenergic signaling suppresses chemokine production in the melanoma microenvironment, limiting TCD8 infiltration and immune-mediated tumor rejection, and 2) beta-blockers may condition the tumor microenvironment to enhance infiltration by adoptively transferred T cells, thereby improving efficacy. We will use a novel model of chronic cold stress as a proxy for generalized -adrenergic signaling, and we will evaluate whether reversing stress can influence the tumor microenvironment and induce or restore TCD8 infiltration and efficacy. The resultant data will provide an enhanced mechanistic understand of tumor-induced suppression of immune responses and potentially establish a conceptual basis to translate our findings into clinical Phase 01 trials that combine -blockers and cancer immunotherapy for the purpose of enhancing T cell infiltration and anti-tumor efficacy.